Multivariate Statistics and Machine Learning for Quality Control of Dried Ocimum Products

PROJECT SUMMARY/ABSTRACT
As the demand for medicinal plant products increases, so does the possibility of adulteration. Authentication of
botanicals is complicated due to the immense quantity of molecular markers, including genetic loci and small
molecules, within plant systems. This complexity also hinders identification of bioactive compounds responsible
for the desired medicinal outputs. However, the improved accessibility of advanced statistical processing allows
harnessing of these species-specific markers for sample identification and biomarker discovery. The overall
hypothesis of this study is that multivariate and machine learning models will streamline multifaceted
natural product investigations. Aim 1 applies multivariate statistics to genetic barcoding and high-resolution
metabolomics data to develop authentication schemes, with Ocimum spp. (basil) as a model system. Random
Forest and Partial Least Squares models are built using greenhouse grown, authenticated basil plants and used
to predict the identity of consumer available products. Aim 2 uses the same statistical approaches to identify
compounds responsible for both basil’s cytotoxic and antimicrobial properties. Developed models will also be
used to predict dual-action bioactivity status of unknown samples. Models with the combined ability to identify
bioactive compounds and samples will be recommended for future studies to improve compound discovery and
classification of bioactive plants. The collection of data, development of statistical models, and professional
development activities described herein will result in the development of a well-rounded, independent
researcher.

Public health relevance
PROJECT NARRATIVE: With increased market demand for medicinal plant products comes a greater risk for adulteration of botanicals, posing a large health risk to consumers. The innate complexity of herbal products makes authentication and identification of bioactive compounds challenging. Thus, this proposal aims to combine advanced metabolomic (UPLC-HRMS), DNA barcoding, and bioactivity data with multivariate statistical models and machine learning algorithms for improved authentication schemes and bioactive compound discovery, using Ocimum (basil) as a model species, to develop novel approaches with application to a range of botanical products.